Cancer cell-intrinsic mitochondrial stress responses influence protective immunity

Epithelial ovarian cancer remains the most lethal gynecological malignancy in the United States, where
the 5-year overall survival rate for patients with high-grade serous ovarian cancer (HGSOC) remains dismal at
34%. While the infiltration of T cells into ovarian tumor islets is clearly associated with prolonged survival in
patients with ovarian cancer, recent advances in antitumor immunotherapeutic approaches rarely induce
objective responses in these women. These outcomes reflect an incomplete understanding of the unique
immunobiology of the ovarian tumor microenvironment (TME). Emerging evidence from our laboratory indicates
that cancer cell-intrinsic dysfunction of mitochondrial stress response dramatically impairs the progression of
ovarian cancer through provoking elevated antitumor immune responses.
Mitochondrial fidelity is tightly linked to overall cellular homeostasis. The hostile nature of the ovarian
TME, where cells encounter conditions of hypoxia, nutrient deprivation, and elevated oxidative stress, drive
mitochondrial dysfunction. Such mitochondrial stress triggers adaptive responses to restore mitochondrial
homeostasis, which facilitates malignant progression. Further understanding the cellular response to
mitochondrial stress in ovarian cancer may be particularly important, as our laboratory has identified a germline
encoded nonsynonymous single nucleotide polymorphism in the gene BLTP3A (found in ~18% of the population
and predicted to generate a loss-of-function phenotype) that is associated with dramatically improved survival
for high-grade serous ovarian cancer (HGSOC) patients. While the role BLTP3A in cancer remains elusive,
preliminary research by our laboratory has revealed that BLTP3A promotes mitochondrial homeostasis through
facilitating mitophagy in HGSOC. Specifically, BLTP3A promotes tethering of lysosomes with autophagosomes
to drive the elimination of damaged mitochondria. However, dysfunctional BLTP3A promotes damaged
mitochondrial accumulation - this generates inflammatory responses through cGAS/STING and elicits elevated
orchestration of cellular antitumor immune responses through type I interferon activity. In fact, our new data show
that HGSOC specimens expressing polymorphic M1098T BLTP3A demonstrate elevated numbers of effector T
cells in these tumor beds. This was observed in association with the emergence of a distinct type I interferon
signature in these tumors: likely driven by active cGAS/STING signaling. Additionally, we have clarified that
BLTP3A functions as a mitochondrial stress response molecule by associating with autophagic machinery to
regulate the turnover of damaged mitochondria though mitophagy. Here, we will utilize our unique mouse
models, reagents, and our extensive ovarian tumor bank to further characterize the biology of BTLP3A and its
impact on the orchestration of protective immunity in ovarian cancer.

Public health relevance
Project Narrative Ovarian cancer is the deadliest gynecological disease in the United States. Although T cells in the ovarian carcinoma microenvironment can spontaneously exert clinically relevant pressure against malignant progression, current immunotherapies rarely induce the regression of ovarian cancers. The work detailed in this proposal will elucidate the mechanisms by which the poorly characterized molecule, BLTP3A, restrains protective immunity in ovarian cancer; gaining this mechanistic insight will pave the way for the design and development of rationale combinations of more effective immunotherapeutic agents for ovarian, and likely other, cancers.